Administrative Core

SUMMARY ADMINISTRATIVE CORE
The Administrative Core is the overarching organizational unit and serves as the main communication arm of
the Mount Sinai Untargeted HHEAR Lab Hub, working directly with the HHEAR Coordinating Center (CC),
Data Center (DC) and NIH program staff. We collaborate and communicate with the other Lab Hubs on QA/QC
programs including proficiency testing and common QC pools, technical replicates and blinded duplicates, and
methods to minimize batch effects and inter-lab variability, issues for which our team played key roles in the
first grant cycle of CHEAR. We coordinate internally to maximize efficiency and can nimbly alter our priorities
as directed by the CC. We organize weekly Steering Committee (SC) meetings of the Hub to coordinate intra-
Hub work flow including receipt of sample shipments, re-labeling, tracking, and entry in to our laboratory
information management system (LIMS). We organize PI/Client consultation meetings in which we review the
parent study for design, sample specimen availability, study subject exposure scenarios, health phenotypes,
and requested types of chemicals exposures to be measured. We will then make recommendations that best fit
the PI/Client's goals, while addressing any scientific or technical issues that may limit feasibility prior to
conducting assay analysis. We also track the progress of on-going jobs and generate regular reports to the
Coordinating Center and NIH program. We coordinate data reporting with the HHEAR Data Center (DC),
ensuring that our databases are properly formatted and contain the appropriate metadata. We also collaborate
with the DC and Client/PI in the interpretation of results, (e.g. how specific gravity or sample evaporation may
impact metabolomics measures in urine) and the statistical analysis of exposure/phenotype relationships. We
will organize and implement an annual Lab Hub workshop that will engage existing and potential clients in
Exposure Biology assay methodologies. We were the only Lab Hub to organize such a meeting under CHEAR
– the New York Exposome Symposium (November 2 - 3, 2018) which drew 200 scientific participants. We use
a web based LIMS interface for tracking job progress through the Lab Hub system and to assess QA/QC in
real time during analysis. In sum, we 1) coordinate communication internally within the Lab Hub and externally
with the Coordinating Center, Data Center, PI/Clients and NIH program; 2) develop the procedures, protocols
and system checks to ensure samples flow to the correct Resource/Core and that QA/QC protocols are
followed rigorously; 3) maintain a LIMS that is user friendly, facilitates sample tracking, prevents mismatches
between samples and results, and integrates with the needs of the Data Center; 4) provide scientific
consultation services to PI/Clients that maximizes the information and quality of their study results; 5) ensure
that feedback communication occurs between Clients and Resources/Cores and that this information is relayed
transparently to the CC and NIH and 6) ensure transparent fiscal management of the Lab Hub program.